Dissecting the Genetic Basis of Congenital Diaphragmatic Hernias in Mice

PROJECT SUMMARY
Congenital diaphragm hernia (CDH) is a common and severe structural birth defect arising in 1 of every 3,000
live births and leading to mortality in an estimated 30-50% of patients. CDH is caused by either a weakening or
partial loss of diaphragm skeletal muscle, allowing abdominal contents to herniate into the thoracic cavity, often
leading to severe lung hypoplasia. The severity of CDH is directly related to the location in the diaphragm
muscle sheet where the defect arises, with more dorsal hernias correlating with higher severity and morbidity.
Though it is clear from human studies that CDH is largely a genetic disease, the genetics are complex and
much remains unknown about the number and nature of the genes and pathways that underlie the defect. This
is in part due to limitations in the number of functional validation studies as the diaphragm is a mammalian-
specific structure, and thus only murine model organisms are available to study CDH. The goal of this proposal
is to study both the genetics and cellular mechanisms underlying CDH using new gene-editing and
transcriptional profiling techniques in the mouse model organism. From high-throughput sequencing of CDH
patients, the number of novel variants predicted to underly CDH has grown exponentially. In the first aim of this
proposal, I will optimize a method to rapidly create precise gene edits in the mouse embryo and screen
embryos at the appropriate developmental stage without the need of further breeding. Using this discovery
platform, I will then screen CDH-associated variants discovered from patient genome sequencing cohorts. To
dissect the mechanism by which hernias arise in discrete regions of diaphragm, in aim 2 I will study the cellular
dynamics leading to CDH within in mice homozygous null for the serine kinase encoding gene Cdc42bpb, a
novel mouse model of CDH which develop unique ventral hernias. These studies will reveal key differences in
the development of the symptomatic and asymptomatic forms of CDH. Finally, in aim 3 I will use single cell
RNA sequencing to understand the cell types and lineages driving diaphragm development both temporally
and spatially within the mouse. Using novel spatial gene expression techniques, I will specifically assay for two
hypothesized cell populations in the developing diaphragm, a mesothelial layer surrounding the tissue and a
fibroblast population driving the migration of the tissue across the liver through embryonic development.
Overall, the work proposed will not only further our understanding of the mechanism by which CDH arises, it
will create a novel transcriptional dataset to assist in prioritization of CDH-associated genes and provide a
powerful method to screen disease-associated alleles rapidly in mouse, advancing our understanding of the
genetic basis for CDH.

Public health relevance
PROJECT NARRATIVE The structural birth defect congenital diaphragmatic hernia (CDH) presents as weakening in the mammalian- specific diaphragm muscle, resulting in the invasion of abdominal contents into the lung cavity, which severely impacts lung development and leads to death in 30-50% of the 1 in 3,000 children born with CDH. Due to limitations in the availability of animal models suitable for screening, functional validation of CDH-associated genes and alleles has been slow, and a deep understanding of the cell populations and pathways impacted by genetic variants are lacking. The goal of this proposal is to investigate the cellular mechanisms and transcriptional dynamics driving CDH in the mouse, and to create a rapid discovery platform in gene-edited mouse embryos to screen CDH-associated alleles discovered in human patients.